13th Hershey Developmental Brain Injury Conference

PROJECT SUMMARY/ABSTRACT
The Hershey Conference on Developmental Brain Injury was started in 1997 and has grown to a high-quality
program that attracts international attendees that include physician-scientists, basic scientists, and trainees.
The conference is held every other year, and the site alternates between international and US locations.
Sessions include invited speakers who are luminaries in the field, as well as sessions in which more junior
investigators share their work. This conference offers an amazing opportunity for trainees and young
investigators to meet and interact with senior investigators in the field in a relaxed environment. The scientific
presentations are always outstanding. The 2022 13th Hershey Conference organized by Drs. Sandra Juul,
Elizabeth Nance and Thomas Wood will be held in the Pacific Northwest, outside of Seattle Washington at the
Alderbrook Resort and Spa. We are applying to NIH for support primarily to fund attendance for junior
investigators and trainees. The overall goal of the proposed meeting is to bring together an international group
of scientists whose focus is on neonatal brain injury and repair. This year’s overarching theme will be: Effects
of the environment on prevalence and outcomes of developmental brain injury. This three-day meeting
will include the following sessions: Long-term consequences of developmental brain injury; Brain aging and
susceptibility to second hit events; Epigenetic and microbiome effects; Mechanisms and cellular imaging and
Societal; environmental, and systemic effects on premature/LBW. The meeting has four objectives:
1) To identify clinical paradigms that inform basic science concepts and translate those new basic concepts
into more refined clinical application
2) To explore areas of gaps in our current knowledge, and to include experts in tangential fields to provide
new perspectives on these gaps
3) To promote novel collaborations
4) To promote trainee and junior faculty participation and to identify trainees/junior faculty from racial/ethnic
minorities and underrepresented institutions to attend this conference and develop new collaborations. In
summary, the objective of this R13 is to provide the necessary continued support for trainees and junior
faculty to attend the 13th Hershey Conference on Developmental Brain Injury. Extensive participation of
trainees, both from US and abroad, has been a hallmark of the Hershey Conference. Trainees, both MD
and PhD, constitute 30-40% of all participants. This meeting provides an excellent opportunity for informal
interaction between trainees and the leaders in the field as well as a mechanism for post-doctoral and
visiting scientist recruitment.

Public health relevance
PROJECT NARRATIVE Neonatal brain injury remains the most common cause of infant mortality and morbidity in infants and children and is a tremendous public health problem. The Hershey Conference on Developmental Brain Injury brings together an international group comprised of leaders in this field, esteemed scientists from outside but related fields, as well as a high proportion of young trainees to continue the important discussions and dissemination of information constantly geared towards finding new and better modes of intervention and neuroprotection.